Engineering the Vocal Fold Extracellular Matrix

DESCRIPTION (provided by applicant): Normal vocal fold vibration is crucially dependent upon tissue composition and viscoelasticity. When composition of the extracellular matrix (ECM) of the vocal fold cover (i.e. lamina propria - superficial and middle layers) is altered, vocal fold vibratory function can be severely disrupted due to alterations in tissue viscoelasticity. The dysphonias that result are generally difficult to treat effectively with current surgical paradigms and available biomaterials. Treatment failures have been ascribed to poor understanding of pathologic processes in the ECM, as well as suboptimal materials that may negatively affect vocal fold biomechanical properties. Accordingly, there is a clinical need for improved understanding of the pathophysiology of disrupted ECM and the development of advanced biomaterials that appreciate the biomechanical properties of the lamina propria. The long-term aim of this project is to engineer injectable products that promote wound repair and induce tissue regeneration, for treatment of scarring and other existing ECM defects of the lamina propria, exclusively for the superficial and middle layers. For the proposed funding period, we will specifically focus on chemically modified injectable synthetic ECM (sECM) hydrogels (HA derivatives) for tissue regeneration. These products will mimic and augment the existing ECM and yield optimal vocal fold ECM biomechanical properties. We will employ a unique combination of systematic chemical, biomechanical, in vitro and in vivo studies to resolve the complex interactions among cell and biomaterial characteristics, biomechanical properties and influences on cell behavior and the surgical requisites necessary to create a suitable clinical outcome. The overarching hypothesis is that manipulation of the ECM with injectable HA hydrogels and sols that have been encapsulated with living cells will yield optimal tissue composition and biomechanically optimal results.

Public health relevance
PUBLIC HEALTH RELEVANCE: Voice disorders affect an estimated 3-9% of Americans yearly and 29% of the population in their lifetime. Treatment for vocal fold scarring, a voice disorder caused by connective tissue or ECM injury or loss has been limited. The proposed research defines a novel and fundamental tissue engineering approach to repair vocal folds with longstanding damage due to injury or disease PROJECT NARRATIVE Voice disorders affect an estimated 3-9% of Americans yearly and 29% of the population in their lifetime. Treatment for vocal fold scarring, a voice disorder caused by connective tissue or ECM injury or loss has been limited. The proposed research defines a novel and fundamental tissue engineering approach to repair vocal folds with longstanding damage due to injury or disease __SpecificAimsTextDelimiter__ A. Specific Aims Normal vocal fold vibration is dependent upon tissue composition and viscoelasticity. When composition of the extracellular matrix (ECM) of the vocal fold cover (i.e. lamina propria - superficial and middle layers) is altered, as in vocal fold scarring, vocal fold vibratory function can be severely disrupted due to changes in tissue viscoelasticity.(7, 8, 26, 27) The dysphonias that result are generally difficult to treat effectively with current surgical paradigms and available biomaterials. Treatment failures have been ascribed to poor understanding of pathologic processes in the ECM, as well as suboptimal materials that may negatively affect vocal fold biomechanical properties. Accordingly, there is a clinical need for improved understanding of the pathophysiology of disrupted ECM and the development of advanced biomaterials that appreciate the biomechanical properties of the lamina propria. The long-term aim of this project is to engineer injectable products that induce tissue regeneration to treat vocal fold scarring and other ECM defects of the lamina propria. In our previous funding period, we optimized a hyaluronic acid (HA) hydrogel for prophylactic use as a means of improving wound healing (see Progress Report). Presently, the sECM hydrogels are being successfully translated in three fields: human medical devices (ENT -- laryngology and orthopedics); wound care and reparative veterinary medicine; and 3D cell culture materials for cell therapy, drug discovery, and stem cell research. For the proposed funding period, we will specifically focus on using chemically modified injectable synthetic ECM (sECM) hydrogels (HA derivatives) for tissue regeneration. These products will be seeded with cells, will mimic and augment the existing ECM and yield optimal vocal fold ECM biomechanical properties. We will employ a unique combination of systematic chemical, biomechanical, in vitro and in vivo animal studies to resolve the complex interactions among cell and biomaterial characteristics, biomechanical properties and influences on cell behavior and the surgical requisites necessary to create a suitable clinical outcome. The overarching hypothesis is that in vivo manipulation of the ECM with injectable HA hydrogels and sols that have been encapsulated with living cells will yield optimal tissue composition and biomechanically functional results. This work has three specific aims. Aim 1. To evaluate the capacity of HA/elastin, oxophilic, self assembling multiblocks and thixotropic hydrogels as tissue substitutes for existing ECM defects in the vocal fold lamina propria. Treatment of existing tissue defects represents a significant clinical challenge. During the previous award period, we developed a unique biocompatible in situ crosslinkable, synthetic ECM (sECM) hydrogel to serve as a tissue substitute for facilitation of wound healing. In this proposal, we will explore three new variants on this sECM: (i) elastin-modified hydrogels, (ii) oxophilic hydrogels, and (iii) thixotropic hydrogels. First, elastin-like peptides will be incorporated to improve the elasticity of material. Second, perfluoroalkyl block copolymers will be incorporated to augment the oxygen availability. Third, novel thixotropic HA materials will be incorporated to improve cell-attachment and mechanical properties. Each of these new sECMs will be engineered with optimized shear-thinning and viscoelastic properties to best meet the vibrational frequencies encountered in phonation and to minimize degradation and resorption, for prolonged facilitation of tissue regeneration. The linear viscoelastic properties of the derivatives will be quantified. Cytocompatibility assays will also be performed. This aim is novel and highly significant in providing a clinically relevant material for tissue regeneration specifically designed for the vocal fold lamina propria. Aim 2. To identify and quantify the effects of mechanical stimulation on cell characterization and regeneration of the ECM of the vocal fold lamina propria. Consideration of mechanical stimulation on cell function is integral in vocal fold lamina propria tissue regeneration. An in vitro bioreactor will be optimized to test the effects of vibratory and mechanical stress on differing cell types (vocal fold and dermal fibroblasts, adult stem cells - bone marrow and adipose and induced pluripotent stem cells). Histological, molecular, and biomechanical alterations of the cells will be quantified to determine optimal cell choice for cellular therapy. Aim 3. To evaluate cell-hydrogel interactions through cell coculture stimulation and spatial organization to optimize tissue regeneration for existing ECM defects in the vocal fold lamina propria. Success in tissue engineering of the vocal fold lamina propria will require a clearer understanding of how cells integrate signals presented in their microenvironment by biomaterial scaffolds. Histological, molecular and biomechanical (rheological) outcomes will be investigated in our HA hydrogel derivatives seeded with cells alone, in coculture within a three dimensional context and in an established animal model. This aim is essential to quantify, in vitro and in vivo, how cell-cell, cell-biomaterial interactions can be exploited to direct tissue regeneration and to support a future clinical trial in human participants.